COMPARATIVE SUB ENGSTRVM ANALYSIS FROM THERMOPHILIC &MESOPHILIC METALLOENZYMES

The long term viability and propagation of all living cells depends upon DNA repair enzymes that process abasic sites created by the loss of the associated purine or pyrimidine base. A key enzyme for the detection and processing of these DNA lesions is Endonuclease IV, an evolutionarily conserved ~30 KDa Zn-dependent metallo-endonuclease. We have grown crystals of Endonuclease IV from the mesophilic and hyperthermophilic bacteria E. coli and T. maritima, respectively, and both crystals diffract x-rays to greater than 1 E as evidenced by preliminary data sets. Ultrahigh resolution diffraction experiments on BL 9-1, using long exposures and an optimized wavelength, will yield sub-Engstrvm data that will be used to define the structural biochemistry of this critical DNA repair enzyme.